Regulation of dendritic cell inflammatory responses

DESCRIPTION (provided by applicant): Dendritic cells (DC) exist at the crossroads of innate and adaptive immunity and therefore play a complex and critical role in the host response to infection and in maintenance of self-tolerance. DCs recognize pathogens through a variety of receptors, and this can result in pathogen internalization and rapid production of cytokines that contribute to the inflammatory response. This pathogen recognition also leads to the upregulation of cell surface MHC molecules and costimulatory molecules, which enables DCs to become potent antigen presenting cells presenting pathogen-derived peptides to naive T cells. In this way, DCs are essential for the adaptive immune response, but can also promote autoimmunity if not properly regulated through the inflammatory presentation of self-antigens. DAP12 and FcR3 are two DC-expressed signaling adapters that signal through immunoreceptor tyrosine-based activation motifs (ITAMs). The ITAM-bearing signaling adapters DAP12 and FcR3 regulate DC function in several ways. In vitro, DAP12 and FcR3 inhibit Toll-like receptor (TLR) responses and regulate the anti-inflammatory effects of apoptotic cells on DC function. In vivo, DAP12 and FcR3 regulate DC numbers and contribute to neutrophilia through increased systemic IL-17. Most importantly, DAP12 and FcR3 regulate the maintenance of self-tolerance-DAP12-/-FcR3-/- mice develop lupus-like disease with anti-nuclear antibodies, Ig deposition in the kidney glomeruli and glomerular destruction. The aims of this proposal seek to define the mechanisms by which DAP12 and FcR3 regulate dendritic cell responses in vivo and in vitro with the goal of identifying how these receptors help protect from the development of lupus-like autoimmunity. Specifically, we will 1) identify the FcR3-associated immunoreceptors required for inhibition of TLR responses in conventional and plasmacytoid dendritic cells; 2) test the hypothesis that DAP12 and FcR3 in dendritic cells control neutrophil homeostasis by regulating DC responses to apoptotic cells; and 3) determine if lack of DAP12 and FcR3 specifically in DCs causes the anti-nuclear antibody production and lupus-like disease seen in DAP12-/-FcR3-/- mice. We have shown that DAP12 and FcR3 regulate several aspects of dendritic cell function-TLR signaling, responses to apoptotic cells, and maintenance of self-tolerance-all of which have been associated with the development of lupus-like autoimmunity in mice and humans. The aims of this proposal seek to define the mechanisms by which DAP12 and FcR3 regulate dendritic cell responses in vivo and in vitro with the goal of identifying how these receptors help protect from the development of lupus-like autoimmunity. These studies will not only help elucidate how dendritic cell function is regulated during immune responses, but also how dendritic cell activation is regulated in the steady state. This work will give insights into how to manipulate the immune system to prevent the development of systemic autoimmunity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Dendritic cells are important in initiating both inflammatory responses and immune responses. These studies will help elucidate how dendritic cell function is regulated both in the absence and presence of infection. This work will give insights into how to manipulate the immune system to achieve more efficient elimination of pathogens and to prevent the development of systemic autoimmune disease, such as systemic lupus erythematosus. Project Narrative Dendritic cells are important in initiating both inflammatory responses and immune responses. These studies will help elucidate how dendritic cell function is regulated both in the absence and presence of infection. This work will give insights into how to manipulate the immune system to achieve more efficient elimination of pathogens and to prevent the development of systemic autoimmune disease, such as systemic lupus erythematosus. __SpecificAimsTextDelimiter__ 2. Specific Aims Dendritic cells (DC) exist at the crossroads of innate and adaptive immunity and therefore play a complex and critical role in the host response to infection and in maintenance of self-tolerance. DCs recognize pathogens through a variety of receptors, and this can result in pathogen internalization and rapid production of cytokines that contribute to the inflammatory response. This pathogen recognition also leads to the upregulation of cell surface MHC molecules and costimulatory molecules, which enable DCs to become potent antigen presenting cells that can activate naïve pathogen-specific T cells. In this way, DCs are essential for the adaptive immune response, but can also promote autoimmunity if not properly regulated through the presentation of self-antigens in an inflammatory, non-tolerogenic manner. DAP12 and FcRγ are two DC-expressed signaling adapters that signal through immunoreceptor tyrosine-based activation motifs (ITAMs). We show here that the ITAM-bearing signaling adapters DAP12 and FcRγ regulate DC function in several ways. In vitro, DAP12 and FcRγ inhibit Toll-like receptor (TLR) responses and regulate the anti-inflammatory effects of apoptotic cells on DC function. In vivo, DAP12 and FcRγ regulate DC numbers and contribute to neutrophilia through increased systemic IL-17. Most importantly, we have found that DAP12 and FcRγ regulate the maintenance of self-tolerance-DAP12-/-FcRγ-/- mice develop lupus-like disease with anti-nuclear antibodies, Ig deposition in the kidney glomeruli and glomerular destruction. The aims of this proposal seek to define the mechanisms by which DAP12 and FcRγ regulate dendritic cell responses in vivo and in vitro with the goal of identifying how these receptors help protect from the development of lupus-like autoimmunity. Aim 1: To identify the FcRγ-associated immunoreceptors required for inhibition of TLR responses in conventional and plasmacytoid dendritic cells. In this aim, we will use gain-of-function and loss-of-function techniques to identify the FcRγ-associated receptors that inhibit TLR responses in conventional DCs and plasmacytoid DCs. This includes the identification of novel FcRγ-associated receptors expressed in DCs Aim 2: To test the hypothesis that DAP12 and FcRγ in dendritic cells control neutrophil homeostasis by regulating DC responses to apoptotic cells. This aim will examine the cause of neutrophilia in DAP12-/- FcRγ-/- mice. We hypothesize that deficiency in DAP12 and FcRγ does not allow for appropriate inhibition of IL- 23 secretion from DCs upon encounter with apoptotic neutrophils, leading to increased IL-23, IL-17A and G- CSF production and increased granulopoiesis. We will also determine the contribution of DAP12 and FcRγ in DCs and neutrophils to the neutrophilia in DAP12-/-FcRγ-/- mice. Aim 3: To determine if the lack of DAP12 and FcRγ specifically in DCs causes the anti-nuclear antibody production and lupus-like disease seen in DAP12-/-FcRγ-/- mice. We will use several systems to address the requirement for DAP12 and FcRγ in DCs for induction of lupus-like disease. We will ask if DCs lacking DAP12 and FcRγ are more efficient at inducing anti-nuclear antibodies in a DC transfer models. We will also generate a mouse model where ITAM signaling is specificaly disrupted in DCs (CD11c-CRE/Sykfl/fl) to ask whether DAP12 and FcRγ expresion in DCs is required to suppress the development of systemic autoimmunity. We have shown that DAP12 and FcRγ regulate several aspects of dendritic cel function-TLR signaling, responses to apoptotic cells, and maintenance of self-tolerance-all of which have been associated with the development of lupus-like autoimmunity in mice and humans. The aims of this proposal seek to define the mechanisms by which DAP12 and FcRγ regulate dendritic cell responses in vivo and in vitro with the goal of identifying how these receptors help protect from the development of lupus-like autoimmunity. These studies will not only help elucidate how dendritic cell function is regulated during immune responses, but also how dendritic cell activation is regulated in the steady state. This work will give insights into how to manipulate the immune system to prevent the development of systemic autoimmunity.